Neuroplasticity and cerebral blood flow as key resilience mechanisms in the brains of fast-moving SuperAgers

Project Summary: The gradual loss of physical and cognitive ability has been taken as the near-universal
consequence of growing older. Older adults slow down physically, with reduced gait speed and increased
instability, and slow cognitively, with declining memory and executive function. Disease pathologies can
accelerate these declines and are the focus of most aging research. Nonetheless, exceptions to these
trajectories can be identified, most notably cognitive “SuperAgers,” who retain the working memory of people
30 years younger. Initial research on SuperAgers has focused only on cognition studied through static, MR-
based neuroimaging and cytoarchitectural examination of post-mortem brains. However, as mounting evidence
demonstrates fast movement is a distinguishing feature of health and longevity in older adults, our research
emphasizes the dynamic interaction between brain neural and vascular function during physical movement.
Our preliminary data illustrate that older adults age 75+ years with exceptionally fast walking speeds and who
are free of cognitive decline – who we have termed fast-moving SuperAgers - display a robust capacity for
neuroplasticity induction (measured with electroencephalography (EEG)) and remarkably high cerebral blood
flow (measured with transcranial Doppler ultrasound (TCD)) during whole-body behavioral learning. Motivated
by these captivating data, this DP2 project will test the novel hypothesis that fast-moving SuperAgers are
enriched in unique neuroplasticity and cerebrovascular profiles that are neuroprotective and enable remarkably
high physical and cognitive function as they near or enter their 9th and 10th decade.
This project embraces a systems-neuroscience perspective to study neuroplasticity induction and interactions
with real-time cerebrovascular function in the unique aging phenotype of fast-moving SuperAgers. We utilize a
highly innovative, multimodal approach (EEG, biomechanics, TCD) to quantify the adaptation of cortical and
biomechanical responses to repeated standing balance perturbations. We synergistically assess real-time
cerebral blood flow velocity during this balance learning task and interactions with cortical plasticity induction.
We will compare the state and longitudinal trajectory of neuroplasticity and cerebrovascular function in fast-
moving SuperAgers to their normally- and slow-moving peers under the same learning conditions. These
results could identify key functional neuroprotective mechanisms of brain aging to be leveraged and targeted
with future interventions to prevent decline of cognition and physical function. The development of targeted,
physiologically-informed interventions through a lens of brain resilience for neurodegenerative diseases such
as dementia would be especially impactful because current pathology-focused treatments (e.g. anti-amyloid
drugs) are extremely limited. Findings gleaned through our innovative conceptual and technical approach to
study human aging neurobiology could pave the way towards a new resilience-focused framework, enabling us
to make impactful scientific discoveries to improve the lives of aging Americans.

Public health relevance
Project Narrative: Neuroplasticity is facilitated through physical movement and may provide a key neuroprotective mechanism by which some exceptional older adults maintain extremely high function well into the advanced stages of aging. This proposal will use an innovative and multimodal approach to characterize neuroplasticity and brain vascular function in a cohort of 75+ year-olds who walk at exceptionally fast speeds and are free of cognitive decline and dementia, and whom we have termed “fast-moving SuperAgers.” This proposal aims to substantially increase our current scientific knowledge of brain resilience in the face of advanced aging, with the goal of helping older adults maintain cognitive and physical function and prevent aging decline and disease.